Homolog bi-orientation and segregation in oocyte acentrosomal meiosis

In the first meiotic division, homologous chromosomes linked by chiasmata attach to microtubules from
opposite poles of the spindle (bi-orientation) and then segregate. Errors in chromosome segregation in the
oocyte lead to aneuploidy and are the leading cause of miscarriage, infertility and birth defects. In the oocytes of
many organisms, including mammals and insects, meiotic spindle assembly occurs in the absence of
centrosomes. We use Drosophila melanogaster females as a model to understand the mechanisms that promote
accurate chromosome segregation on the acentrosomal spindle of oocytes. We are interested in understanding
the mechanisms of bi-orientation and the features of the oocyte spindle that make it susceptible to chromosome
segregation errors. From our previous research we have shown that the kinetochore interacts with the
microtubules in two ways. First, lateral attachments, where the kinetochores move along the sides of
microtubules, establish bi-orientation. Second, end-on attachments, where the kinetochores make a stable
attachment to the ends of microtubules, maintain connections to a pole and segregate the homologs. Stabilizing
end-on attachments too rapidly leads to errors in chromosome segregation. The lateral interactions important for
bi-orientation occur between the kinetochores and central spindle, which are composed of overlapping
antiparallel microtubules and may be particularly important for acentrosomal oocytes. Our proposed studies are
focused on understanding how the kinetochores and central spindle interact to regulate the transition from
lateral to end-on attachments and accurately segregate chromosomes.
1) Investigate the mechanisms of meiotic kinetochore assembly
2) Investigate how the meiotic kinetochore ensures accurate bi-orientation
3) Investigate how the central spindle interacts with kinetochores and promotes bi-orientation
These three Aims are linked by a goal to understand the mechanisms of chromosome segregation important to
oocytes. In completing this work, we will have identified mechanisms required for kinetochore assembly and
for regulating the transition from lateral and end-on kinetochore-microtubule attachments. We will also
determine the role of the central spindle in this process, which we believe is a mechanism of bi-orientation that
is particularly important in acentrosomal oocytes.

Public health relevance
Aneuploidy, or an abnormal chromosome number, is a leading cause of spontaneous abortions and infertility in women and also causes diseases such as Down, Turner or Klinefelter syndromes. The object of this research is to understand how oocytes receive the correct number of chromosomes and the mechanisms of errors that lead to aneuploidy.